Structural studies of metazoan origin licensing

Project Summary
Developing effective cancer therapies remains a significant challenge due to the heterogeneity of tumor
physiology, cytotoxicity towards non-cancer cells, and the emergence of drug resistance, all of which hamper
positive patient outcome. Thus, there is a critical need for novel anticancer agents with alternate mechanisms
of action. Targeting the DNA replication initiation pathway is an underexplored strategy for cancer therapy.
Origin licensing, the first step of DNA replication initiation during which the replicative helicase Mcm2-7 is
loaded onto replication origins, is of particular interest because its inhibition is selectively cytotoxic towards
cancer cell lines. However, no origin licensing inhibitors have been developed for clinical therapy yet, which is
in part due to an incomplete mechanistic understanding of DNA replication initiation in metazoans. Contrary to
S. cerevisiae, which has been used extensively to study replication initiation both at the biochemical and
structural level, no structures of metazoan origin licensing intermediates containing Mcm2-7 on-pathway to
helicase loading have been solved. How small-molecule origin licensing inhibitors bind and inhibit Mcm2-7
loading factors is likewise unknown. These gaps in knowledge have impeded the development of effective drug
candidates targeting replication initiation. The goal of this proposal is to uncover structural insights into
metazoan origin licensing. A deep understanding of metazoan origin licensing will aid in the
development of small-molecule inhibitors targeting DNA replication initiation complexes and in
defining the mechanisms by which these inhibitors act. These results will contribute to the long-term goal
of developing origin licensing inhibitors as a new class of cancer drugs.

Public health relevance
Project Narrative The inhibition of DNA replication initiation is a promising new strategy for cancer therapies, but more research is needed to fully understand mechanisms of replication initiation in metazoans. This project seeks to understand how higher eukaryotes load the replicative helicase Mcm2-7 onto DNA replication origins, and how this process is inhibited by small molecules. This study will provide a greater understanding of molecular mechanisms of DNA replication initiation in higher eukaryotes, which will identify new drug targets and assist in the development of improved DNA replication initiation inhibitors.